Project 1

PROJECT SUMMARY
Acute myeloid leukemia (AML) has a 5-year survival rate of ~30%. Despite new treatments, these rates have
changed little with virtually all patients developing relapsed/refractory AML. Thus, there is a strong clinical need
to improve treatment outcomes for this disease. In this regard, our P01 team has built the foundational research
showing that enhancement of the cellular levels of ceramide (Cer), a pro-death sphingolipid (SL), is a therapeutic
avenue for AML. Additionally, the investigators of this P01 program developed a novel endogenous Cer
generator, Cer nanoLiposomes (CNL), which cooperates with current standard of care (SOC) therapeutics in
preclinical AML models. Our goal is to improve the efficacy of both CNL & current SOC AML therapeutics by
ablating CNL/Cer “clearance” pathways linked to AML clonogenic survival. One such Cer clearance pathway has
been highly overlooked: the conversion of Cer to ceramide-1-phosphate (C1P) by the enzyme ceramide kinase
(CERK). In preliminary studies, CERK inhibition (CERKi) dramatically increased Cer levels and significantly
reduced the viability & clonogenicity of multiple AML cell models with no effect on normal controls. In
collaboration, CERKi was also found to induce a novel form of cell death and cooperate with CNL, venetoclax,
and other Cer generators (SACLAC). These data infer that CERK clears a differential cellular “pool” of Cer from
those enhanced by SACLAC & CNL, which forms the premise that a combinatorial approach of multiple Cer
generators & SOC therapeutics with CERKi will increase the levels of differential Cer “pools” & be highly
efficacious in AML. Mechanistic studies showed that CERKi in AML cells also collapsed key aspects of
dysregulated AML metabolism required for clonogenic capacity (e.g., pentose phosphate pathway). Intriguingly,
these aspects of AML metabolism are regulated by members of the direct C1P interactome. Therefore, we
hypothesize that CERK-derived C1P is a “rheostat” for essential aspects of dysregulated AML metabolism via
direct and sustained activation of pivotal factors. We further hypothesize that CERK is an advantageous target
to induce additional Cer “pools” & novel cell death mechanisms for the enhancement of AML therapeutic efficacy.
Our hypotheses will be interrogated by three specific aims: 1) Determine the therapeutic potential of targeting
CERK in AML using state-of-the-art preclinical models of AML and a novel CERK inhibitor. Computational
models of SL metabolism will be utilized to predict the sensitivity of specific patient AML cells for sensitivity to
CERKi and cooperation with other Cer generators; 2) Determine the cellular topology and role of CERK in
modulating key aspects of dysregulated AML metabolism & therapy resistance using flux sphingolipidomics and
novel molecular constructs to modulate C1P formation in specific cell compartments. Genome-wide metabolic
models will identify key vulnerabilities in AML metabolism affected by CERKi; and 3) Determine the C1P
interactome modulating AML metabolism and mitochondrial function using Haberkant proteomics coupled to
biophysical (e.g., surface plasmon resonance) and molecular methods (e.g., CRISPR/Cas9).

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) is the 2nd most common type of leukemia diagnosed with few significant improvements achieved over the past 40 years. In the proposed study, we posit that targeting specific bioactive lipids will augment the efficacy of standard of care therapeutics and have a substantive impact on AML treatment.